Characterizing the Effects of Sequence Variability in Molecular Function, Evolution and Design

Proposal Summary
Biological sequences that perform a functional role evolve via changes that tend to preserve their original
function or by the acquisition of new properties that might confer a fitness advantage. The processes that lead
to novel functional sequences or those that explain a negative effect given a biomolecular change are not yet
fully understood. Solving this puzzle is challenging given the complex network of interactions and constraints
that biomolecules are subject during evolution. This MIRA project aims to continue our efforts to understand,
characterize and utilize landscapes of sequence variability and the effect of sequence change on function and
fitness of biomolecules. We have developed tools based on epistatic probabilistic models, latent generative
models, and evolutionary dynamics to have a predictive understanding on how sequence composition as well
as novel sequence space leads to biomolecules with certain functional properties and fitness. Over the past years
we have made contributions and providing evidence that it is possible to construct coevolutionary models using
extant sequence data that can infer if novel sequences will have certain functional properties or if the changes
will be detrimental. In this project, we propose to continue developing techniques based on state-of-the-art
computational techniques in machine learning that are aided by our interpretable epistatic models to 1) increase
the accuracy of our sequence fitness landscape determination and navigate landscapes effectively, 2) be able to
design and experimentally test novel biomolecules with desired functional properties, 3) understand the
dynamics of functional preservation in pathogenic molecules that might aid the forecasting of variants that can
contribute to disease or antibiotic resistance. This project will allow us to expand our developments of Latent
Generative Landscapes (LGL) and models of sequence evolution with epistatic contributions (SEEC) to work
with new and more complex systems as the ones we have worked in the past, including metal transporters,
temperature sensing proteins, proteases, viral proteins, and antibiotic resistance enzymes. Our key hypothesis
is that an accurate modeling of the latent manifold of the protein sequence space will lead us to a better inference
of functional classification of many uncharacterized proteins, help us understand and fine-tune the most
important determinants for functional selectivity and predict evolutionary trajectories of biomolecules that
could then be used for therapeutic purposes like vaccine development and drug design.

Public health relevance
Public health relevance statement The space of potential bio-sequences is so large that identifying and characterizing those configurations that lead to biological function is challenging. This project aims to continue developing computational, probabilistic, and learning methods combined with experimentation that can lead to a clearer picture of the functional landscape of biomolecular variability. This framework will ultimately lead to a better understanding of the effects of mutation in disease, evolutionary pathways for pathogens and the optimal design for novel biomolecules inspired in extant sequences found in nature.